Novel MYBPC1 mutations cosegregate with a myopathy associated with muscle weakness, hypotonia and tremor

Abstract
Myosin Binding Protein-C (MyBP-C) comprises a family of accessory proteins that directly interact with
both thick myosin and thin actin filaments. Three distinct isoforms have been characterized, including the
cardiac (c), slow (s) skeletal and fast (f) skeletal. During the last forty years, numerous studies have focused on
the biology of cMyBP-C primarily due to its high mutational prevalence in heart disease. On the contrary, the
regulation and roles of the skeletal isoforms have been mainly inferred due to the structural similarity they
share with cMyBP-C. Our group has been studying the biology of sMyBP-C aiming to understand its regulation,
roles, and disease association. Our findings are highly novel and intriguing. First, we found that MYBPC1, the
gene that encodes sMyBP-C, is heavily spliced giving rise to multiple variants that can be co-expressed in the
same muscle and myofiber. Second, the presence of alternatively spliced insertions affects the ability of the
NH2 and COOH termini to bind actin and myosin, and regulate the formation of actomyosin crossbridges in
vitro. Third, the NH2-terminus of sMyBP-C undergoes extensive PKA- and PKC-mediated phosphorylation,
which is altered in disease. Fourth, sMyBP-C has both structural and regulatory roles with its structural role in
the organization and maintenance of thick myosin filaments preceding its regulatory role in modulating cross-
bridge cycling. Fifth, four novel, dominant, missense mutations located in the NH2-terminal M-motif of sMyBP-C
co-segregate with of a new myopathy characterized by muscle weakness, hypotonia, facial and body
deformities, and high-frequency irregular tremor. Molecular modeling and biochemical studies indicated that
the four myopathic mutations differentially affect the ability of the NH2-terminus of sMyBP-C to bind myosin,
and the structure and stability of the M-motif. We therefore hypothesize that the four MYBPC1 mutations may
differentially alter the biochemical and biophysical properties of sMyBP-C compromising its structural and
regulatory roles, yet elicit similar myopathic phenotypes. We further propose that mutant sMyBP-C results in
the formation of abnormal and deregulated cross-bridges, which in addition to causing a deficit in force
production underlying muscle weakness, act as the primary pacemaker of the observed tremor. The goal of our
proposal is to comprehensively study the pathogenesis of this novel form of MYBPC1-associated myopathy
using a combination of sophisticated in vitro approaches (Aim 1) and novel preclinical models (Aims 2 & 3).
The proposed studies are highly significant in terms of discovery science as we will mechanistically examine
the etiologies of this myopathy, and impactful in terms of translational/clinical research for accurate disease
diagnosis as well as appropriate and effective treatment design.

Public health relevance
Narrative Contraction of skeletal muscle is a highly regulated process, which involves the sliding of thin actin filaments past thick myosin filaments. When this process is compromised, skeletal myopathies arise with symptoms that vary from mild to severe, and phenotypes that range from muscle weakness and debilitation to death. Myosin binding protein-C (MyBP-C) comprises a family of important regulators of muscle contractility, and is expressed in both skeletal and cardiac muscles. Consistent with this, mutations in the genes encoding the cardiac and slow skeletal isoforms have been causally linked with the development of hypertrophic cardiomyopathy and distal arthrogryposis, respectively. Our studies will focus on the involvement of the slow skeletal MyBP-C isoform in a new form of myopathy accompanied by muscle weakness, hypotonia, body deformities and tremor. Our overarching goal is to understand the molecular etiologies underlying this myopathy and the origin of the tremor phenotype. The obtained information will be highly novel and impactful in the long term for disease diagnosis and effective therapeutic design.